Ryanodine receptor structure and function in heart failure

Project Summary
The overarching goal of this PPG is to define the molecular mechanisms that regulate local calcium (Ca2+)
signaling in normal and failing hearts with unprecedented precision. There are three goals shared by the four
projects: 1) explore the precise role of adrenergic signaling in modulating calcium in normal and failing hearts;
2) define novel mechanisms of interactions between T-tubule and sarcoplasmic reticulum (SR) calcium channels;
3) develop new understandings of genetic based mechanisms of inherited forms of CV disease involving calcium.
Project four provides the essential link to SR calcium release by studying the structure-function relationships of
the type 2 ryanodine receptor (RyR2)/calcium release channel present on the sarcoplasmic and endoplasmic
reticula (SR/ER) of many cell types in the context of heart failure (chronic HF with reduced ejection fraction,
HFrEF). RyR2 channels are required for Ca2+ release from intracellular stores that triggers excitation-contraction
(EC) coupling in the cardiac muscle. Inherited RyR2 mutations can cause arrhythmias including exercise-induced
sudden death or catecholaminergic polymorphic ventricular tachycardia (CPVT), and stress-induced post-
translational modifications of RyR2 contribute to heart failure (HF) progression. In both cases RyR2 channels
are leaky either due to inherited mutations (CPVT) or acquired post-translational modifications (HF). Unanswered
questions include: 1) can (and if so how) RyR2 mutations can cause HF; 2) what is the precise mechanism by
which PKA phosphorylation activates RyR2 and plays a role in HF? Preliminary data using cryo-EM to solve the
structure of human RyR2 at ~2.4 Å show that a human CPVT mutation RyR2-R2474S puts the channel into a
“primed state” from which it can be readily and pathologically activated at low, normally non-activating [Ca2+]cyt
explaining why these channels are leaky and cause fatal ventricular arrhythmias during exercise or stress. The
Rycal drug ARM210 binds to RyR2 and restores the mutant channel back to a stable closed state preventing
leak and arrhythmias. The applicant hypothesizes that RyR2 missense mutations, 14 of which are found in
patients with a ClinVar prediction of cardiomyopathy in patients from the Pakistan Genome Resource (PGR), a
unique cohort of individuals with extensive phenotype data and high rates of consanguinity, (Core A), may be
gain of function (GoF) mutations that also put the channel into a primed state which is even more sensitive to
activation compared to the CPVT mutations. Thus, these patients have leaky RyR2 channels and develop HF
due to depletion of SR Ca2+ resulting in impaired cardiac contractility. These questions will be addressed using
functional and structural assays and using a novel drug, Rycal (ARM210), that fixes the RyR2 mediated SR
Ca2+ leak via a well-defined mechanism. Three aims are proposed: 1) Evaluate changes in the function and
structure of RyR2 GoF missense variants linked to heart failure (HFrEF); 2) Evaluate the effect of Rycal on the
structure/function of human RyR2 and disease related variants; and 3) Examine the molecular mechanism by
which adrenergic signaling regulates RyR2 function in normal and failing hearts.

Public health relevance
PROJECT NARRATIVE The overarching goal of the parent PPG is to define the molecular mechanisms that regulate local calcium (Ca2+) signaling in normal and failing hearts with unprecedented precision. There are three goals shared by the four projects: 1) explore the precise role of adrenergic signaling in modulating calcium in normal and failing hearts; 2) define novel mechanisms of interactions between T-tubule and sarcoplasmic reticulum (SR) calcium channels; 3) develop new understandings of genetic based mechanisms of inherited forms of CV disease involving calcium. Project four provides the essential link to SR calcium release by studying the structure- function relationships of the type 2 ryanodine receptor (RyR2)/calcium release channel present on the sarcoplasmic and endoplasmic reticula (SR/ER) of many cell types in the context of heart failure.